Genetic dissection of dementia

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The major goal of this research is to identify the genetic risk factors with functional significance to dementia in the model organism Drosophila melanogaster. The key aspect of dementia is age-dependent neurodegeneration that cripples executive functions (e.g. inhibitory control) and memory. Most dementia studies have focused on memory loss, which is a prominent symptom of AD - the most common dementia type. While animal models have provided important insights into the mechanism for memory loss, their utility for dementia gene discovery is limited since the study of memory loss is time-consuming and laborious. Executive deficits are major symptoms in early-stage AD and related dementias yet largely understudied. We overcome these limitations by studying inhibitory control deficit as a dementia endophenotype for the discovery of dementia genes, which is innovative. Our approach is to conduct an unbiased screen for the genetic loci causing dysfunctional inhibitory control in an age-dependent manner, with or without the non-genetic risk factors. In this proposal we will also test the hypothesis that the genetic and non-genetic risk factor interaction has a greater effect on dementia than a genetic factor alone. Drosophila is tractable for student research training and education as it is easy to handle, allows to readily apply state-of-the-art tools and approaches, and is cost-and time-effective; thus, this research fits well with the R16 funding mechanism.

Public health relevance
Alzheimer’s disease and other dementias are chronic and progressive diseases without cure, imposing a huge health economic burden in our society. The proposed research is directed at advancing our knowledge of dementia etiology, which would facilitate the development of new prevention and therapeutic strategies.